Leveraging Digital Health Solutions to Reduce Learning and Functional Disparities in Children with Cancer - Diversity Supplement

Project Summary/Abstract
As the population of childhood cancer survivors grows, the impact of long-term treatment-related side effects
also grows. Cancer treatments for children with leukemia and lymphoblastic lymphoma (LL) have long-lasting
toxic effects on the developing brain, known as neurocognitive late effects, which can impact the children’s
learning, function, and ability to achieve independence as adults. However, these problems are often untreated
in leukemia and LL survivors, creating a medically underserved population. Recognizing the impact of familial
factors on survivor outcomes, we designed a parent-directed training intervention (the high-intensity intervention
program, HIP), which teaches parents about brain development and neurocognitive late effects; trains them on
tools to improve their child’s behavior and cognitive functioning; provides tips for establishing better learning
environments and effective study habits; and helps them to manage stress for themselves and their children.
Pilot trials of the HIP in English- and Spanish-speaking families demonstrated efficacy but also revealed critical
barriers to success, including travel time and scheduling challenges. Digital health technologies offer
transformative solutions to improve the efficiency, quality, and convenience of healthcare delivery. However,
“eHealth” has not been applied to a parent-directed intervention to improve educational outcomes for children.
Therefore, we propose to test a new eHealth version of our English/Spanish intervention (HIP-eHealth) in a
randomized clinical trial of 166 parent/child dyads from 4 sites in California. HIP-eHealth addresses the remaining
barriers to HIP access and incorporates improvements recommended by parents in our earlier trials. We will
deliver HIP-eHealth from a single central site (City of Hope) through a HIPAA-compliant study website that hosts
Zoom videoconferencing for HIP sessions; digitized study content; supplemental multimedia content; links to the
award-winning IXL learning environment; gamification features and automated reminders to increase
engagement; and robust user analytics. Other advances include a streamlined 4-session program, an enhanced
booster phase, and greater inclusion of the children. We hypothesize that HIP-eHealth will produce greater
improvements in child and parent outcomes than a lower-intensity program (LIP) that mimics the usual care
provided to survivors of pediatric brain tumors (i.e., a single meeting to discuss the child’s neuropsychological
testing results and provide recommendations for optimal learning). Our study aims to: (1) Evaluate the
effectiveness of HIP-eHealth on the learning and school performance of pediatric cancer survivors; (2) Evaluate
the effectiveness of HIP-eHealth on the “pro-learning” efficacy of their parents; (3) Investigate the extent to which
the parents’ efficacy and/or children’s use of online learning activities is associated with changes in the children’s
school performance; and (4) Assess factors that impact the parents’ ability to complete the intervention. We
anticipate this study will help shape a scalable and effective therapy that is easily integrated into standard care.

Public health relevance
PROJECT NARRATIVE This study will evaluate the ability of a targeted eHealth parent-directed intervention to reduce the burden of cancer survivorship by improving psychosocial and behavioral outcomes in the underserved population of childhood leukemia and lymphoblastic lymphoma survivors. We anticipate that leveraging digital health solutions will produce an effective, scalable therapy that overcomes key barriers to follow-up care and is easily integrated into care delivery.